Novel bioengineered microRNA therapeutics for lung cancer

PROJECT SUMMARY
Lung cancer remains the most lethal cancer among both women and men in the United States. There is a clear
need for developing new and more effective therapeutics for the treatment of lung cancer, especially the most
predominant subtype non-small cell lung cancer (NSCLC). As posttranscriptional gene regulators, the
genome-derived microRNAs (miRNAs or miRs) govern many critical cancer cellular processes such as
proliferation, invasion, and stemness. Therefore, restoration of tumor suppressive miRNAs (e.g., miR-124-3p
(miR-124)) lost or downregulated in NSCLC cells represents a novel therapeutic approach. However, current
research relies primarily on the use of chemo-engineered miRNA mimics (ChemoRNAs) synthesized in vitro and
comprised of extensive and diverse types of artificial modifications at various locations, which are different from
natural RNA molecules produced and tolerated in vivo that do not contain any modifications or just a few
necessary posttranscriptional modifications. Our past and ongoing efforts have led to a patented platform
technology to achieve a robust, high-yield, and large-scale in vivo fermentation production and use of true
biologic or bioengineered RNA agents (BioRNAs). We have demonstrated that BioRNAs, consisting of only
several natural modifications, are precisely processed to target miRNAs (or siRNAs) to selectively regulate target
gene expression in human NSCLC cells and subsequently, inhibit NSCLC cell proliferation and invasiveness as
well as tumor progression and metastasis. Among the NSCLC-relevant biologic RNAs, we have identified a few
lead miRNAs (e.g., miR-124 and miR-22-3p (miR-22)) consistently exhibiting potent antiproliferative activities
against multiple NSCLC cell lines. Our preliminary studies have also showed that BioRNA/miR-124 is more
efficacious than commercial ChemoRNA/miR-124 to regulate target gene expression and NSCLC cell viability,
and miR-124 may control NSCLC immunity via modulating specific immune regulator and checkpoint protein
levels. Further, we have found that miR-22 controls NSCLC metabolism through the regulation of key nutrient
metabolic enzymes and transporters. Moreover, humanized BioRNA/miR-124 and miR-22 lipopolyplex
monotherapy effectively reduced tumor progression in animal models without causing any hepatic or renal
toxicity or severe immunogenic effects. Given such exciting preliminary findings, we hypothesize that novel
bioengineered RNA molecules can be utilized to modulate NSCLC metabolism and immunity to improve
therapeutic outcomes of current medications via pharmacodynamic and pharmacokinetic interactions. To test
the hypothesis, we propose to define the biosimilarities between model Bio- and Chemo-RNA molecules by
side-by-side comparing their efficacy and specificity in the regulation of target gene expression and inhibition of
NSCLC cell growth (Aim 1), delineate the molecular pharmacological actions of lead BioRNAs in the control of
NSCLC cell metabolism and immune checkpoint (Aim 2), and establish the effectiveness and safety of BioRNAs
to improve the therapeutic outcomes of co-administered drugs in vivo (Aim 3). The proposed research will
establish BioRNAs as one-of-a-kind RNA molecules for research and open new directions for the development of
novel biologic RNA therapeutics for the treatment of NSCLC.

Public health relevance
PROJECT NARRATIVE The proposed studies will establish novel bioengineered ribonucleic acid molecules made through in vivo fermentation production as first-in-class tools for research and development, minimally an addition to conventional agents synthesized in vitro. The lead ribonucleic acids may be used to modulate human lung cancer cell metabolism and immune checkpoint to improve the treatment of lethal lung cancer.